Linking neural mechanisms of emotion and attention with naturalistic trauma symptom experience: An event-related potential and ecological momentary assessment study

Project Summary: Around 70% of individuals will experience a significant traumatic event in their lifetime.
Although the presence of any trauma is associated with disruptions to cognitive and emotional reactions to
everyday events, experiencing an interpersonal trauma (e.g., assault, abuse) is associated with increased
symptoms of post-traumatic stress (PTS) relative to impersonal traumas (e.g., disasters, accidents), and
appears to follow a separate, more severe symptomatic etiology. Collectively, symptoms following a traumatic
event (i.e., intrusive thoughts, avoidance symptoms, negative alterations to cognitions and mood,
hypervigilance and reactivity) cause substantial burden on both individual functioning and behavioral health
services. While the presence of all four of these symptom clusters comprise a diagnosis of Post-Traumatic
Stress Disorder (PTSD), affecting 8.3% of individuals in their lifetimes, an additional 14.7% will experience sub-
threshold symptoms of PTS, associated with similar functional difficulties to PTSD (i.e., depressive symptoms,
psychiatric comorbidity, social/occupational difficulties, impulsive coping and substance use, increased
aggression/hostility, and suicidal ideation). However, most research on PTS utilizes a categorical approach to
symptom differentiation, combines trauma types that may have separate etiological pathways, relies on cross-
sectional research designs, and fails to incorporate multiple units of analysis. The present study utilizes a
transdiagnostic approach to assess neurocognitive vulnerability and the daily experience of PTS symptoms by
incorporating electroencephalography/event-related potentials (EEG/ERP) to assess neural mechanisms of
emotion regulation and attention to idiographic, trauma-relevant stimuli. Baseline self-report measures of
symptoms will be supplemented with ecological momentary assessments (EMA) for a two-week follow-up
period to assess daily symptoms of PTS and reactions to acute stressful events in naturalistic settings. Project
aims include (1) To assess if emotion regulation and attention bias to idiographic stimuli relevant to an index
trauma can establish neural markers for PTS and (2) To investigate if EMAs can be used to detect differences
in frequency and severity of symptoms of traumatic intrusions, hypervigilance and reactivity, negative
cognitions and mood, and avoidance symptoms following daily negative experiences. Multilevel models will be
used to integrate these data to assess the relationship between baseline neural markers and daily trauma
symptoms. The objectives and directions of this research are consistent with the NIMH Strategic Plan,
specifically by assessing mental illness by probing the course of PTS symptomatology in the aftermath of
psychologically disruptive events (i.e., trauma) through the analysis of biological, behavioral, and
environmental contributors to symptom heterogeneity with techniques integrating repeated ecological
assessments. This project aims to integrate understanding of biological and behavioral indicators of
dimensional constructs of PTS that carry implications for novel treatment targets and the prediction of symptom
course and severity.

Public health relevance
Project Narrative Following a traumatic experience, individuals may experience symptoms of distress and dysregulated emotional response, especially when reminded of the events; however, most research fails to assess how neural mechanisms of emotion regulation and attention to idiographic stimuli (i.e., autobiographic stimuli relevant to the details of a trauma) relate to the experience of these symptoms in naturalistic settings. This study will integrate electrophysiological assessment of neural mechanisms of emotion regulation and attention with ecological momentary assessments of post-traumatic stress symptoms. Findings have the potential to identify neurocognitive vulnerabilities for post-traumatic stress and inform future interventions through the development of models of state-level stress reactions alongside baseline trait measures of attention and emotion regulation.